Synaptic and Circuit Mechanisms of Learned Motor Sequences

Project Summary/Abstract
This project aims to investigate the neural mechanisms that lead to complex behavioral sequences, such as
hitting a tennis forehand or playing the piano. To accomplish these behaviors, the brain must stitch together each
component movement into a coherent act. Both local and long-range synaptic inputs can play a major role in
generating the underlying premotor commands that drive these actions, but their respective influences can often
be difficult to distinguish. We investigate this issue by examining the neural circuit dynamics underlying the
courtship song of the zebra finch. Birdsong is a complex behavior that consists of precisely executed vocal
elements mediated by a dedicated set of anatomically distinct brain regions. We recently found that thalamic
drive engages a specific subpopulation of premotor neurons within the zebra finch song nucleus HVC (proper
name) and that these inputs are critical for the progression between song elements. Here we investigate how
such long-range inputs interact with local circuit properties to advance our understanding of the neural processes
governing skilled movements across species.
In Aim 1, we will test the relative impact of local and long-range excitatory input on singing. To accomplish
this, we will measure the behavioral consequences of optogenetic silencing of two primary afferent streams to
HVC. We will then use in vivo voltage clamp recordings and glutamate imaging to test the related hypotheses
that long-range inputs have specific temporal and spatial patterns at the level of individual postsynaptic neurons.
Finally, we will test the hypothesis that intrinsic excitability may affect network function by relating cellular
properties of individual neurons to their role in singing behavior.
In Aim 2, we will examine the contribution of local circuit inhibitory interneurons to HVC network dynamics.
We first identify functionally defined categories of interneurons with distinct behavioral roles. We will then
determine whether each inhibitory subpopulation exhibits distinct connectivity patterns within the network, and
we will use a novel hybrid intra-/extracellular approach to examine their influence onto premotor neurons. Finally,
we will leverage a newly developed family of viral tools to test the hypothesis that these functionally defined
interneuron groups are mediated by molecularly distinct cell classes.
Taken together, our proposal will examine how local and long-range inputs direct cortical dynamics in the
context of an ethologically relevant behavioral sequence. Our findings will have clear implications for the
understanding of mammalian behaviors in health and disease.

Public health relevance
Project Narrative The proposed project is relevant to public health because understanding how forebrain circuits enable behavioral sequences will help to illuminate the processes underlying the acquisition and performance of skilled movements. Thus, this research is relevant to the NIH’s mission to contribute to the body of knowledge needed to develop novel therapies for treating those who experience motor disorders.